Comparative systems biology defines regulatory mechanisms in whole-body regeneration

Project Summary
Whole-body regeneration (the ability to regenerate all body parts) is one of the greatest mysteries in biology.
Harnessing this process would be a medical moonshot triumph, as it would provide therapeutic strategies to
enable regrowth of any type of missing tissues in human patients. In order to understand and control
regeneration, we need to uncover the full regulatory network of the regeneration program, and identify critical
mechanisms that may lead to the dysfunction of this network. Here, we propose to use new functional genomic
analysis tools (Spatial Transcriptomics, ATAC-seq, and single-cell transcriptomics) coupled with high-
throughput gene perturbation experiments to study two unique experimental paradigms. In the first paradigm,
we will compare two evolutionary cousins: the freshwater planarian, which is an immortal flatworm with
unparalleled regenerative ability throughout the animal kingdom, and the pathogenic flatworm schistosome,
which only has limited regenerative ability. We will reveal the critical regulatory components of the short-term
wound-induced response that are essential for launching and sustaining regeneration. In the second paradigm,
we will study surgically constructed planarian chimeras to unravel the immunological pathways that regulate
regeneration in order to manage the long-term risks of uncontrolled cell proliferation that is associated with
repeated regeneration. Collectively, our study will advance the understanding of the fundamental biological
basis of regenerative medicine and provide useful targets for activating regeneration.

Public health relevance
Project Narrative Whole-body regeneration (the ability to regenerate all body parts) is one of the greatest mysteries in biology. Harnessing this process would provide therapeutic strategies to enable tissue regrowth in human patients after any type of traumatic injury or surgery. The proposed studies will establish the fundamental knowledge that is needed to understand and control the regulatory program(s) of regeneration.